Channel activity during skin morphogenesis

Our long-term objective is to understand the principles that orchestrate skin morphogenesis in development
and wound regeneration. The understanding of biochemical signaling is well advanced. Yet, research into the
roles of non-neural bioelectricity lags behind, although evidence for a role of bioelectricity in development,
regeneration (McLaughlin and Levin 2018 16; Li et al., 2020 5) and wound healing (Zhao et al. 2012 32) is
growing. Our research objective is to study the mechanisms underlying the development and regeneration of
skin appendages. In two of our recent research papers, we were inspired to see bioelectricity in action in two
tissue patterning processes. First, the orientation of elongating feather buds is regulated by synchronization of
oscillating calcium channel activities in bud dermal cells, which is controlled by epidermal Shh signaling (Li et
al., 2018 11). Second, the skin frequently shows pigment stripes along the body. The size and spacing of
longitudinal pigmentation stripes in Japanese quail was recently shown to be controlled autonomously within
melanocyte progenitor populations in a gap junction-dependent manner (Inaba et al., 2019 12). At the time
these periodic black/yellow stripes form in embryos, the spacing is in millimeters, a large-scale patterning
process that cannot be explained by the classical Turing reaction-diffusion mechanism (patterning in
micrometer range). The results led us to think hard about how large-scale tissue architecture is built. While
localized signaling centers involving morphogens (e.g., WNT, BMP, FGF) were shown to initiate periodic
patterning of feather/hair buds, some unidentified mechanism capable of spanning large distances dynamically
must work together to transduce the information over the long-distance scale (Inaba and Chuong, 2019 15).
Bioelectricity work here provides a clue. Thus, we organized a multi-disciplinary team to analyze the
mechanisms on how biochemical and bioelectric signals integrate to achieve the large-scale tissue patterning.
We hypothesize, among other possibilities, transient bioelectrical signaling across gap-junction-coupled cell
collectives may allow rapid, long-distance signaling with minimal decrement. Electropotential gradients are
harnessed to propagate signals rapidly over the long distance (millimeters in milliseconds) to regulate
intracellular messengers and pattern the much larger morphogenetic field. The developing avian skin explants
provide an excellent model because of the quantifiable distinct patterns, planar topology for easier channel
activity visualization, electric current perturbation and optogenetic gene activation – not easy in the mouse
model. Experimentally, we will first gauge the endogenous bioelectric landscape and evaluate the importance
of bioelectricity in these two tissue patterning processes (Aim 1A, 2A). Then we will study how ion channels /
gap junctions cross-talk with biochemical signals to achieve tissue patterns (Aim 1B, 2B). The work is likely to
produce new findings and insights for future applications to use bioelectricity to benefit wound regeneration.

Public health relevance
Narrative: We seek to learn how to harness the ability of ion channels and electric fields in tissue development and regeneration. To this end, we will explore the role of ion channels and bioelectric fields in guiding tissue development using two avian skin morphogenesis models: 1) the orientation of feather bud elongation along the anterior – posterior axis, 2) the patterning of alternating yellow and black longitudinal pigment stripes in Japanese quail.